Southwest Safety Net Embedded Scientist Training and Research (SSNE-STaR) Center

Project Summary Overall Core
The US healthcare system struggles to provide quality care to the most underserved populations. The safety
net organizations (SNOs) serving these populations have limited capacity to support scientists conducting
embedded research or rapid evidence implementation. Building a research infrastructure within SNOs to
create and implement culturally sensitive evidence-based approaches to improve health equity is an urgent
unmet need. The US Southwest has among the worst disparities in the nation, but a robust system of SNOs.
Arizona State University College of Health Solutions (ASU CHS) and Valleywise Health (VH) will create the
Southwest Safety Net Embedded Scientist Training and Research (SSNE-STaR) Center. The SSNE-
STaR vision is to improve the health equity of historically disadvantaged populations, with a strong
commitment to the needs of American Indians, Hispanic, homeless, and other underserved populations. The
SSNE-STaR will support the scientific training and professional development of Scholars embedded across
Arizona SNOs to produce evidence-based research and gain proficiency in rapid-cycle implementation. The
SSNE-STaR is a collaboration among academic and diverse safety net organizations including inpatient and
ambulatory care health systems, federally qualified health centers, Tribal health centers, community partners,
and other stakeholders, with equity as a cross-cutting focus, and primary care, maternal care, and disabilities
as research priorities. ASU is a Hispanic Serving Institution focused on inclusion, health equity, and
continuous improvement. VH is the only public teaching hospital and health care system in Arizona, providing
services to underserved, low-income, and ethnically diverse populations, over 60% Hispanic. Other SNO
partners include: Native Health of Phoenix, Inter Tribal Council of Arizona, Value Based Care, Veterans
Administration (VA) Hospital, and Phoenix Children’s Hospital. The SSNE-STaR will establish a new Learning
Health System (LHS) model to support physicians and scientists embedded in SNOs that provide care to
underserved populations. The SSNE-STaR will recruit and train embedded health scholars throughout
Arizona. Our LHS Scholars will be selected from healthcare professionals throughout the VH system and our
extensive network of SNO partners. Embedded Scholars will be recruited from a network of Native American
health centers and other regional SNOs. The Center will be supported by an extended research finding
dissemination and implementation network of safety net organizations. ASU brings PCOR experience to the
SSNE-STaR as a partner in the PCORnet Patient-Centered Network LHSnet (2015-2019), and ASU is
currently engaged in a formal collaboration with PCORnet partner, the Greater Plains Collaborative (GPC)
Clinical Data Research Network (CDRN).

Public health relevance
Overall Project Narrative: Southwest Safety Net Embedded Scientist Training and Research (SSNE-STaR) Center Arizona State University College of Health Solutions (ASU CHS) and Valleywise Health (VH) System will create the Southwest Safety Net Embedded Scientist Training and Research (SSNE-STaR) Center. Our goal is to help improve the health equity of historically disadvantaged populations, with a strong commitment to addressing the needs of Native American, Hispanic, homeless, and other underserved populations. We will support the scientific training and professional development of Scholars embedded across Arizona Safety Net Organizations (SNOs) to conduct comparative effectiveness and patient-centered outcome research (CER/PCOR) and gain proficiency in rapid-cycle implementation.